Microaggressions and Hazardous Drinking among non-Latinx Black Individuals with Chronic Pain

PROJECT SUMMARY/ABSTRACT
Hazardous drinking and chronic pain are both highly prevalent and frequently comorbid public health
conditions that exact a significant burden on patients, providers, and health care systems.1,2 Indeed, non-Latinx
Black adults with chronic pain are more likely to report greater pain intensity, increased avoidance of activities
due to pain, greater fearful thinking related to pain, and greater physical and psychological disability in the
context of their chronic pain experience when compared their non-Latinx White counterparts.3-6 Despite there
being lower rates of drinking among non-Latinx Black adults, they experience greater negative consequences
(e.g., alcohol dependence symptoms and social consequences) for drinking than non-Latinx White adults.7
Additionally, compared to their non-Latinx White counterparts, alcohol-dependent non-Latinx Black adults have
an increased likelihood of experiencing recurrent and persistent alcohol dependence.8 Minority stress-based
models of substance use and mental health outcomes posit that marginalized groups, such as non-Latinx
Black adults, are vulnerable to problematic substance use via common racial/ethnic microaggressions (MAs),
defined as verbal or non-verbal indignities that insult or put down people because of their race/ethnicity.9
Extant work among non-Latinx Black individuals has only initially documented the negative impact of MAs on
alcohol use.10 There is a need to understand the longitudinal nature of MAs and alcohol use motivation (i.e.,
greater alcohol craving, intention to drink, and coping-oriented motives for alcohol use) and drinking (i.e.,
greater alcohol consumption, greater frequency of drinking, and more negative consequences from drinking)
among non-Latinx Black adults who are hazardous drinkers with chronic pain. The proposed research project
supports the 2017-2021 strategic plan of the National Institute on Alcohol Abuse and Alcoholism (NIAAA) by
advancing research in two of the key areas. First, the current proposal has the goal of improving strategies to
prevent alcohol misuse, alcohol use disorder, and alcohol-related consequences among an ‘at-risk’ population
for these conditions (goal 3). Second, it enhances the public health impact of NIAAA-supported research, by
focusing on one of the largest demographics in the US who demonstrate disparities in hazardous drinking (goal
5). Further, the proposal contributes to research on health disparities and comorbidities, which represent two of
the cross-cutting research themes of NIAAA.
2

Public health relevance
PROJECT NARRATIVE The co-occurrence of hazardous drinking exacts a significant burden on patients, providers, and health care systems. In line with NIAAA initiatives to increase greater understanding of individual differences factors that may underlie the etiology and maintenance of alcohol misuse and its comorbidities and NIH’s UNITE initiative’s aim to support “new research on health disparities, minority health, and health equity,” the proposed work will examine the influence of microaggressions (MAs) (accounting for non-discriminatory daily stress) on alcohol use motivation, drinking, and alcohol-related problems as well as pain experience among non-Latinx Black adults who are hazardous drinkers with chronic pain. Through this research, we also will explore mediational processes and moderators in the MA-hazardous drinking/pain relations that will inform future intervention and prevention efforts for this neglected health disparities group. 3